Developing and credentialing patient-derived xenograft models to advance therapeutic approaches for chronic myelomonocytic leukemia

Project Summary/Abstract
Chronic Myelomonocytic Leukemia (CMML) is a lethal subtype of leukemia characterized by cytopenias, marrow
dysplasia, monocytosis, and a propensity for transformation to acute myeloid leukemia (AML). Until this R37
parent grant, no mouse model of CMML, to include genetically engineered mice harboring CMML mutations,
had recapitulated the unique clinical or histological characteristics of the human disease. We have overcome
this limitation and generated phenotypically and genetically accurate PDX models of 92 CMML patients through
the use of modified NOD/SCID IL2R null (NSG) mouse strains expressing human cytokines that uniquely drive
CMML. Moreover, we have utilized these PDX models to identify novel therapies targeting aberrant cytokine-
signaling characteristics and mRNA splicing in specific genetic subsets of CMML. In this R37 extension we
propose to leverage our CMML PDX model to study a previously unrecognized observation we have made that
approximately 20% of CMML patients harbor a very small concomitant mast cell clone. Because these cases
are clinically and genetically unique, we hypothesize that there may be an ongoing but unknown biologic
cooperativity in these patients. However, to study this accurately, new in vivo systems are needed to model this
clone-to-clone communication. We aim to achieve this with our CMML PDX models in two specific aims: In Aim
1 we will generate the first hybrid CMML PDX in which mast cells will be additionally heterotopically xenografted
with the goal of modeling clone-to-clone communication. Because our preliminary data suggest that subclonal
mast cells may be derived from the same ancestral stem cell as CMML, we will also retrospectively determine if
CMML and de novo mast cells were previously xenografted in CMML PDX models already generated from
patients with occult subclonal mast cells. Last, we will use these models to identify secreted factors and annotate
the clonal architecture of these patients at single cell resolution. In Aim 2 we will determine if SF3B1 mutated
clones have distinct biologic cooperativity and secreted factors. Our preliminary clinical data suggests that
SF3B1 mutations are enriched in patients with subclonal mast cells. We hypothesize that this is due to a unique
genotype specific cooperativity. We will evaluate this by xenografting isogenic leukemic cells with and without
SF3B1 mutation in the context of a concomitant mast cell tumor. We will also compare CMML PDX models with
and without concomitant mast cell tumors in the context of SF3B1 mutation generated in aim 1. Last, we will
compare the secreted factors and clonal trajectories identified in Aim 1 in SF3B1 mutant versus wild type CMML
PDX. Collectively, this extension will build on the parent grant by using our CMML PDX model to explore novel
biology that could translate to a better understanding of the disease and novel therapeutic strategies.

Public health relevance
Project Narrative Chronic myelomonocytic leukemia (CMML) is an aggressive blood cancer for which we unfortunately have no curative therapies. Our group has now identified that 20% of CMML patients harbor a second subclonal disease that confers unique clinical characteristics. This R37 extension will build on the CMML PDX models generated during the parent grant to model this new discovery, confirm biologic clone-to-clone interactions, and begin to determine how these two distinct clones collaborate to result in fully manifested CMML.